High performance miniaturized microscopes for through skull cortex-wide imaging in freely behaving mice

PROJECT SUMMARY
The mammalian cerebral cortex plays a crucial role in learned and adaptive sensory-motor behaviors, with its
evolutionary expansion contributing to advanced cognitive abilities in humans and primates. While progress has
been made in understanding regional cortical computations, the coordination of neural activity across the cortex
for unified behavioral outputs remains poorly understood. The innovation described involves the development of
the mini-mScope, a miniature imaging device capable of mesoscale dynamic measurements across the cortex
in freely behaving mice. Weighing 3.8g, the mini-mScope has been distributed to several laboratories globally,
demonstrating its efficacy in dorsal cortical activity imaging during various behaviors. Beta testing revealed two
key issues: limited behavior testing and a challenging implantation procedure. The proposed Phase I, Small
Business Technology Transfer (STTR) project aims to address these concerns by engineering a mini-mScope
with a highly sensitive imaging CMOS sensor, evaluating its performance in through-skull imaging, and
comprehensively assessing its imaging capabilities across diverse behavioral contexts. Successful outcomes
are expected to enhance the mini-mScope's commercial viability, facilitating wider adoption for neuroscientific
research.
In AIM 1 of this proposal, we will engineer a mini-mScope with highly sensitive imaging CMOS sensor and
evaluate the imaging performance of the mini-mScope through an intact skull preparation. This will involve
integrating a novel CMOS sensor into the existing device footprint, increasing the effective resolution of the
device, and developing an intact skull preparation to image the brain through the skull without the need for a
craniotomy. The new mini-mScope will be benchtop tested against the device performance of the extensively
validated lab prototype of the mini-mScope.
In AIM 2 of this proposal we will perform comprehensive in-vivo evaluation of the mini-mScope in a broad
spectrum of behavioral contexts and to optimize the opto-mechanical design to perform artifact free imaging.
The in-vivo performance of the mini-mScope will be evaluated in 5 behavioral assays that capture a wide range
of behavioral paradigms used in traditional neuroscience. In conjunction, the opto-mechanical stability of the
device will be optimized to ensure stable, motion-artifact free imaging in all plausible behavioral conditions.

Public health relevance
PROJECT NARRATIVE In this proposal, Objective Biotechnology seeks to develop a commercial-grade miniaturized fluorescence microscope with a high sensitivity CMOS that can perform wide-field calcium imaging through an intact skull. Successful accomplishment of this project will result in a new robust tool for use in pre-clinical neuroscience studies of large scale neural dynamics.